Characterization of cyclic-GMP-cAMP regulation in Vibrio cholerae

ABSTRACT
Vibrio cholerae is a pathogen capable of causing worldwide pandemics including seven in
the scientific record. The seventh pandemic El Tor biotype that displaced the classical
biotype responsible for the first six pandemics differ genetically by many single
nucleotide polymorphisms and the acquisition of two large genetic islands called Vibrio seventh
pandemic islands I and II (VSP-I and VSP-II). The VSP-I island encodes eleven genes,
including dncV which encodes a dinucleotide cyclase enzyme that produces the cyclic-
GMP-AMP (cGAMP) molecule. Virulence studies in the infant mice model of infection revealed
that dncV is the only gene in VSP-I, that when mutated, has a competitive disadvantage
compared to the parental strain. This provides strong evidence that DncV and cGAMP is
important for virulence. How cGAMP regulated downstream pathways to enhance virulence
remained unresolved. Recently, a study revealed that another gene in VSP-I called capV, that is
immediately adjacent to dncV, encodes a phospholipase that is activated by binding to
cGAMP. These results suggest that cGAMP acts on the cell by binding protein receptors in
a manner similar in concept of other cyclic dinucleotides. While the discover of CapV
explained the effect of DncV and cGAMP on lipid metabolism in V. cholerae, the effect of
cGAMP on virulence, MSHA expression and chemotaxis expression are unexplained. This
proposal hypothesizes that additional protein receptor(s) bind directly to cGAMP to mediate
downstream regulation of MSHA, chemotaxis and pathogenesis. We will test our hypothesis
by using biochemical and genetic approaches including: Aim 1. Identifying interacting
proteins of cGAMP and Aim 2. Characterizing cGAMP down regulation of the MSHA
operons. Together, results from the completion of this aim will reveal how cGAMP signaling
occurs in V. cholerae and shed light on the intersection between cGAMP and cyclic-di-GMP
(c-di-GMP), another cyclic dinucleotide molecule also used by V. cholerae. In addition,
revealing the network of signaling molecules in V. cholerae will allow better understand of
pathogens can adapt when they acquire cGAMP signaling via horizontal gene transfer.

Public health relevance
NARRATIVE Cyclic-GMP-AMP (cGAMP) is a nucleotide signaling molecule made by DncV encoded in the genomes of Vibrio cholerae strains from the seventh pandemic and positively regulates bacterial virulence. This proposal seeks to identify the protein receptors of cGAMP encoded by the V. cholerae genome that regulates pathogenicity. Results from these studies will reveal the mechanisms in which cGAMP regulates V. cholerae and other organisms that encode dncV.